CONCURRENT ADMINISTRATION OF CGS 12970 AND ENALAPRIL FOR HYPERTENSION

The purpose of this study is to evaluate the possible synergistic hypotensive effect of concurrent administration of CGS 12970 and enalapril in patients with mild to moderate essential hypertension.